Systems Biology of Aging: Data-science meets Gero-science

PROJECT SUMMARY / ABSTRACT The funds requested in this R13 application are for partial support of “Systems Biology of Aging: Data-science meets Gero-science” annual meetings to be offered each August/September from 2019 through 2022 at The Jackson Laboratory for Genomic Medicine (JAX-GM) in Farmington, Connecticut. This meeting will bring together up to 150 interdisciplinary scientists including molecular biologists, immunologists, computational biologists, and geriatricians, who share a common interest in understanding aging and aging-associated disease at the systems level. Many aging-associated diseases, such as cancer and cardiovascular disease, are influenced by dysfunctions in the immune system. Recent advances in genomic profiling techniques (e.g., single cell transcriptomics) provide an opportunity to uncover aging-related changes in human cells/tissues and to link these changes to health and lifespan. The wealth and complexity of data produced using these technologies is ever increasing, as is the need to develop advanced computational methods to mine and integrate these data. Despite this need, there are currently no formal venues at which scientists, specifically those in the aging field, can be trained in the basics and application of data mining techniques (i.e., machine learning algorithms). Furthermore, current conferences on aging are not aimed at specifically bringing together computational biologists, immunologists and basic and clinical aging researchers. Therefore, the objectives of this meeting are: (1) to recognize and emphasize the highly interdisciplinary nature of the aging field and to promote and accelerate collaborations and cross-pollination of ideas across the three disciplines: aging, immunology, and computational biology; (2) to provide trainees (students and postdoctoral fellows) an opportunity to closely interact with, and gain feedback from, more senior investigators to advance their projects and establish connections to help build their careers; and (3) to provide an opportunity for researchers in the field of aging to learn the basics of machine learning techniques, which they will be able to immediately apply to their own research upon return to their home institutions. We will reach these objectives through carrying out the following Aims. In Aim 1, we will organize an interdisciplinary meeting and hands-on workshop focused on aging and aging-related diseases. The meeting will include a 2-day seminar session featuring talks by leading scientists, followed by a 1-day hands-on workshop on the basics of machine learning. In Aim 2, we will promote interactions to foster collaborative research and career advancement, including through a poster session. In Aim 3, we will recruit diverse attendees. Our proposed speaker list features several female scientists, and we will use our partnership networks to specifically recruit attendees from nationally underrepresented racial and ethnic groups. The ultimate goal of the meeting is to advance the aging research field through expediting collaborations and the understanding of aging-related genomic data via application of advanced data mining approaches.

Public health relevance
PROJECT NARRATIVE / RELEVANCE TO PUBLIC HEALTH Aging and aging-associated diseases, such as Alzheimer's, cancer and cardiovascular disease, represent a significant and growing health and economic burden, with the elderly population of the US projected to double by 2030. Herein, we propose to organize an interdisciplinary conference with a hands-on computational training component that will bring together scientists from the fields of aging, immunology, and computational biology, which will enable creative collaborations and train early career scientists in the aging research field on the basics of advanced computational techniques to mine aging-related genomic data. This is ultimately expected to lead to a better molecular understanding of the aging process and to novel approaches for the improvement of human healthspan and/or lifespan.